Understanding the Short- and Long-Term Impacts of School-Based Health Centers

PROJECT SUMMARY/ABSTRACT
School-based health centers (SBHCs) aim to improve child and adolescent health by providing health care at
schools. SBHCs have become increasingly widespread in recent decades, with over 2,500 SBHCs serving more
than 6 million students. While existing research finds that SBHCs are positively correlated with health care use
and contemporaneous educational outcomes, differences between students at schools with and without SBHCs
may confound these estimates. Moreover, while a large literature shows that childhood health has lasting impacts
on later adult health, human capital, and economic outcomes, surprisingly little is known about the impacts of
SBHCs on students’ long-run trajectories. This project aims to advance knowledge on these issues by using
difference-in-difference models to measure the causal effects of SBHCs on students’ health care utilization and
their short- and long-term behavioral, educational, and economic outcomes. The project will examine the effects
of SBHCs on the provision of psychotropic medications for school-aged youth using 13 years of data covering
the near universe of antidepressant, anti-anxiety, and antipsychotic prescriptions across the entire US linked
with information on the openings of over 1,800 SBHCs. The project will also consider impacts on youth health
care use more generally using nearly a decade of administrative Medicaid claims data covering the entire US.
The project will further estimate the effects of SBHCs on a range of student outcomes—including attendance,
disciplinary actions, high school graduation, college enrollment/graduation, and adult employment and
earnings—using 26 years of administrative data on all public school students in Texas linked with information on
the openings of 54 SBHCs. For student-level outcomes observed before and after an SBHC opening, the
analysis will compare the before/after change in outcomes of students at schools that experienced an SBHC
opening relative to the before/after change over the same period for students at matched control schools without
SBHCs. The analysis of prescription and other health care outcomes will follow a similar design, comparing
before/after changes in outcomes in areas surrounding schools following an SBHC opening relative to the
before/after change over the same period in areas either slightly further away from the treated school or in areas
near matched control schools. For long-term student-level outcomes only observed post-exposure, the analysis
will compare outcomes among students enrolled in schools at the time of the SBHC opening to those who already
aged out of the school relative to the difference between these cohorts at matched control schools. The project
will identify groups of students that are most affected by SBHC access by conducting subgroup analyses by
student characteristics such as race/ethnicity and socioeconomic background. The project will also conduct
separate analyses by service offerings and staffing patterns to compare effects by SBHC characteristics. Results
will help policymakers, schools, health care providers, and parents understand the impacts of SBHCs on youth,
thereby helping inform discussions about further expansions of such centers across the US.

Public health relevance
PROJECT NARRATIVE – RELEVANCE School-based health centers (SBHCs) aim to improve child and adolescent health by providing health care at schools. While over 2,500 SBHCs currently serve more than 6 million students across the US, little is known about the impacts of SBHCs on student trajectories. The central objectives of this project are to: (i) provide causal evidence based on comprehensive pharmaceutical and medical claims data on the effects of SBHCs on youth health care use, (ii) provide causal evidence based on large-scale administrative data on the effects of SBHCs on students’ short- and long-term behavioral, educational, and economic outcomes, and (iii) compare the effects of SBHCs on student outcomes by SBHC and student characteristics. Results will help policymakers, schools, health care providers, and parents understand the impacts of SBHCs on student trajectories, thereby helping inform discussions about further expansions of such centers across the US.